Molecular Genetics of Fat Taste

Summary
Taste contributes to quality of life and healthy eating habits, aiding with the recognition of nutrients in food. The
underlying molecular and cellular mechanisms responsible for transducing the taste of saccharides (sweet),
amino acids (umami), and sodium (salty) have been characterized, but those responsible for detecting fat are
controversial. Our preliminary studies indicate that an orphan G protein-coupled receptor, GPR113, is a bona
fide fat taste receptor, and that the Gα protein GNA14 transduces the fat taste signal from GPR113. Moreover,
we have identified a subset of T1R+ taste cells expressing GPR113 and GNA14 that support fat taste. We
propose to elucidate the roles of GPR113 and GNA14 in T1R+ taste cells. In Aim 1, we will record the
behavioral and electrophysiological responses elicited by fat taste stimuli in Gpr113 knockout (KO) and Gna14
KO mice. In Aim 2, we will use a cell-based assay to deorphanize GPR113 and evaluate the contribution of
GNA14 and T1Rs to the GPR113-dependent transduction pathway. In Aim 3, we will study the role of a
transcription factor, FOXA2, that we hypothesize regulates the differentiation of fat taste cells. Knowledge
obtained from this research will improve our understanding of the taste of fat and provide an opportunity to
consider fat as a basic taste. As part of the project, we will establish a cell-based assay to screen for GPR113
modulators, which could potentially help develop fat taste enhancers that will allow us to reduce fat contents in
our diets.

Public health relevance
Narrative Overconsumption of fat contributes to obesity and its related health problems. Fat is detected by taste and somatosensory systems, but its receptor mechanism is controversial, especially in taste. We propose to conduct behavioral, electrophysiological, and molecular genetic and biochemical studies to characterize a putative fat taste receptor, GPR113; a fat taste transducer, GNA14; and a transcription factor regulating fat taste cell differentiation, FOXA2, which could help develop fat taste enhancers to reduce fat content in our diets.